Mechanistic Intermediates in Copper Oxygenases and Oxidases

Mechanistic intermediates in copper oxygenases and oxidases:
Copper oxygenases and oxidases have a wide range of functions including melanin and siderophore
biosynthesis, neurotransmitter regulation, iron metabolism, and proton pumping for ATP synthesis.
Understanding their reaction mechanisms is both of fundamental importance and has significant downstream
applications in health, biotechnology, and catalysis. There has been much mechanistic speculation based on
structures, model complexes, and calculations. However, the key to determine the enzyme mechanisms and
thus utilize and control their reactions is by trapping catalytic intermediates and defining their structures and
reactivities. Our research combines enzyme kinetics to trap intermediates, a range of spectroscopies to define
these intermediates, and electronic structure calculations correlated to experiments to elucidate reaction
mechanisms. Our focus is on the three classes of copper oxygenases and oxidases. The antiferromagnetically
“coupled” binuclear Cu enzymes include catechol oxidases (CaOx), tyrosinases (Ty), and o-aminophenol
oxidases (AOx) that all utilize the same µ-η2-η2 CuII2O22− intermediate to perform their functions. In Progress,
trapping the ternary intermediate of OxyTy with phenol substrate bound has defined the Ty monooxygenase
mechanism, and our studies are now directed toward determining the mechanisms of the CatOx’s and the AOx’s
and how these enzymes are tuned for their selectivity. The “non-coupled” binuclear Cu enzymes include
dopamine β-monooxygenase that converts dopamine to norepinephrine, the insect homolog tyramine β-
monooxygenase, and peptidylglycine ⍺-hydroxylating monooxygenase. In this class, the two Cu’s are separated
by 11Å resulting in the lack of magnetic coupling. A major point to address is whether co-substrate binding
induces a conformational change to bring the Cu’s together for coupled binuclear O2 activation or if the 11Å
structure is active. If the latter, important issues will be explored including whether O2 activation by a single Cu
(a CuII–O2− intermediate) is able to perform H-atom abstraction and the timing of electron transfer from the 11Å
Cu required to complete the reaction and avoid reactive oxygen species (ROS). The third class is the multicopper
(MCOs) and heme–copper oxidases (HCOs) that reduce O2 to H2O, using different active site structures for
different functions. The MCOs use a trinuclear Cu cluster for efficient oxidation of substrates, while the HCOs
use their binuclear site to pump protons across a membrane for ATP synthesis. Studies on the MCOs are far
along in defining their mechanism of O2 reduction, their role in Fe metabolism with control of ROS, and coupling
to electrodes for fuel cell applications. For the HCOs, intermediates are available that would elucidate the O–O
bond cleavage mechanism and the active site structural changes that enable proton pumping. However, the
dominant spectral features of the hemes have precluded defining the role of the Cu and its Tyr-crosslinked His
ligand in these reaction steps. New spectroscopic methods being developed will enable definition of the complete
Heme/Cu/Tyr active site and its role in the O–O cleavage and proton pumping mechanisms.

Public health relevance
Project Narrative: The copper oxygenases and oxidases play key roles in natural product biosynthesis1, 2, neurotransmitter3, 4, and neuropeptide hormone regulation5, 6, iron metabolism7, 8, and biological energy transduction.9-11 Experimentally elucidating their actual mechanisms and how Nature controls their reactivities is both of fundamental importance and has downstream applications in controlling neurological disorders12-15, understanding melanogenesis in human diseases and agricultural applications16-18, the design of new biocatalysts19, 20, and second sphere control into homogenous21, 22 and heterogenous catalysts23-25, and in the development of new biofuel cells26, 27, including wearable devices.28